IGF::OT::IGF: TASK ORDER 02 MOD 01. NON-CLINICAL ADME STUDIES. POP: 09/19/2016 - 09/18/2021. N01DA-16-8931.PURPOSE: TO OBLIGATE FUNDS TO FULLY FUND PERFORMANCE UNDER TASK ORDER 02 MODIFICATION 02 AN

IGF::OT::IGF: Non-Clinical ADME Studies. N01DA-16-8931.